MPN Research Consortium

Abstract
The Myeloproliferative Neoplasm Research Consortium (MPN-RC) is an inter-active group of laboratory and
clinical scientists from 11 institutions throughout North America who will continue to work in a coordinated
fashion to develop therapeutic strategies intended to improve the survival of patients with the myeloproliferative
neoplasm (MPN), myelofibrosis (MF). The MPNs which also include polycythemia vera (PV), and essential
thrombocythemia (ET) are clonal hematological malignancies which affect at least 300,000 individuals in the
United States and are recognized as rare diseases by the National Cancer Institute (NCI). The Consortium
has received continuous NCI funding since 2006 to elucidate the pathogenetic mechanisms underlying MPNs
and address the unmet clinical needs of MPN patients. In the present application, we have chosen to focus our
efforts on MF since it is the MPN with the shortest survival and at present allogeneic hematopoietic stem cell
transplantation is the only approach which substantially alters its natural history. During the last decade, MF
patients have received enormous clinical benefit from the widespread use of the JAK1/2 inhibitor, ruxolitinib,
which is the first drug approved for the treatment of MF patients. Unfortunately, this drug (and others in the
class) does not substantially halt disease progression and offers minimal improvement in survival. The
limitations of this class of drugs can be attributed to an inability to eliminate MF hematopoietic stem cells (HSC)
and/or disarm supportive microenvironments. To improve MF patient survival, we hypothesize that drugs
capable of effectively depleting MF HSCs but sparing their normal counterparts be utilized. These drugs would
act by directly targeting malignant HSCs and/or by correcting their tumor promoting micro-environments.
Lessons learned from these studies will be useful to scientists and clinicians studying a large number of other
cancers. The overall goal of the MPN-RC is to employ the complementary skills and efforts of its scientifically
diverse membership to generate the scientific foundation for novel therapeutic strategies which will be
evaluated in well-constructed, independent, investigator-initiated early phase clinical trials. To achieve these
goals the following Specific Aims will be pursued: Specific Aim 1: To develop the scientific rationale for the
use of therapeutic agents which deplete or eliminate MF stem cells by directly targeting malignant MPN stem
cells. Specific Aim 2: To target aberrant inflammatory signaling and dysregulated gene expression in MF cells
and in the microenvironment which drives disease progression. Specific Aim 3: To rationally design and
rapidly execute preclinical studies and investigator-initiated phase I/II clinical trials with novel agents, including
biomarker based studies embedded within our clinical trial platform to document efficacy of novel MF
therapies. Specific Aim 4: Actively and dynamically maintain the scientific research and clinical research
infrastructure needed to support and coordinate the performance of all laboratory investigations and clinical
trials planned by the MPN-RC.

Public health relevance
Project Narrative The Myeloproliferative Neoplasm Research Consortium (MPN-RC) is an inter-active group of laboratory and clinical scientists from 11 institutions who will work in a coordinated fashion to develop and evaluate therapeutic strategies that will improve the survival of patients with myelofibrosis (MF). We hypothesize that drugs which act by directly targeting malignant hematopoietic stem cells and/or by correcting their tumor promoting micro-environments can be used to deplete the numbers of cancer stem cells. The overall goal of the MPN-RC is to employ the complementary skills and efforts of its scientifically diverse membership to generate the scientific foundation for novel therapeutic strategies which will be evaluated in rigorous, well- constructed independent investigator-initiated clinical trials.